COMPARE EXPECTATIONS W OUTCOMES WHEN MEASURING SATISFACTION PARAMETERS

The purpose of this protocol is to measure satisfaction parameters from patients participating in clinical research studies in the GCRC and compare the results to their expectations.